Co-evolutionary dynamics between transposable elements and their hosts

Project Summary
Genome stability is necessary for fertility and health. Transposable elements disrupt genome stability by
selfishly replicating within host genomes, producing insertions that disrupt functional sequences and cause
ectopic recombination. Transposable elements are widespread across eukaryotes, and can occupy a
substantial portion of the genome. Organisms defend against transposable element invasion with a complex
system based on small RNA. Essentially, small RNA produced from transposable elements (termed piRNA) is
used as a guide to cleave transposable element transcripts and direct epigenetic silencing. In most organisms,
exemplified by Drosophila, there are separate systems for TE suppression in somatic and germline cells –
somatic suppression is achieved largely by a single canonically transcribed locus. Germline suppression is
achieved by many redundant loci which produce piRNA through non-canonical transcription.
Much of what we know about the function of the piRNA system has been derived from carefully executed
experiments in developmental biology, where typically a single genotype of Drosophila melanogaster is used.
Some of the generalizations from this work are that regions of the genome that produce piRNA are large and
conserved. Furthermore, the primary suppression system is thought to be piRNA targeted heterochromatin or
transcript degradation, despite at least one TE being suppressed by alternative splicing. My lab recently has
made discoveries that bring some of these conclusions into question – for example many germline piRNA
clusters appear to be genotype specific. Even the largest and most prolific piRNA region identified in the
original developmental biology experiments appears to be unimportant for piRNA production in some
genotypes. In addition, the primary locus responsible somatic suppression was thought to be deeply conserved
but we found it to be evolutionarily labile, having duplicated in Drosophila simulans and potentially functionally
diversified. Lastly, alternative splicing of many TEs appears to occur, but we know nothing about how
functionally important this is for TE suppression. This has profound implications for fitness variation in
populations of individuals from Drosophila to humans.
The consequences of transposable element mobilization are dire, yet the system which suppresses them
evolves rapidly and is not well conserved between even closely related species. My lab will work to understand
the forces that generate and maintain variation in the production of piRNA in the defense against transposable
elements, the evolution of piRNA producing regions, and the evolution of alternative mechanisms of
transposable element suppression.
The proposed work represents advances in a number of fields, including population genetics, post-
transcriptional regulation, transcriptional regulation, alternative splicing, and small RNA biology. Taken
together, this research will offer a unified picture of the evolution of host defense systems against transposable
elements which can be extended into humans and other economically important systems.

Public health relevance
Project Narrative Since the 1950’s we have known about the existence of ‘jumping genes’ – transposable elements that selfishly increase in copy number within host genomes. However only recently did we come to understand that the host has a defense system based on small RNAs for combating unchecked proliferation of these genomic parasites. To date we know very little about how this defense system evolves within and between populations to combat new and active transposable elements, or about the actual mechanisms of transposable element suppression by this system. This proposal aims to address this shortfall by developing a comparative genomics approach to the small RNA defense system, both within populations and between species. This will yield new insights into the genomic conflict of transposable elements and their hosts and variability in host susceptibility to transposable elements.